Targeting Latexin Signaling for Endothelial Barrier Dysfunction in Inflammatory Lung Injury

Project Summary
The Acute Respiratory Distress Syndrome (ARDS) is a common cause of respiratory failure in the critically ill,
accounting for ~75000 deaths/year and 3.6 million hospital days. The existing paradigm is that the ARDS results
from widespread dysfunction of the pulmonary endothelium, leading to microvascular thrombosis, interstitial
edema, alveolar flooding and respiratory failure, although the mechanisms leading to endothelial dysfunction
remain unknown. This proposal arises from novel observations linking the upregulation of Latexin to endothelial
dysfunction in the lung. We found that healthy lung endothelium expresses low levels of Latexin whereas levels
markedly increase in response to turbulent flow or bacterial LPS. Further, we found that endothelial barrier
function was enhanced by reducing Latexin expression in LPS-exposed lung endothelial cells and that global
deficiency of Latexin in mice reduced LPS-induced pulmonary edema, lung inflammation and mortality.
Mechanistically, we found that Latexin mediated its effects through complex mechanisms, including binding to the
enzyme Src kinase and facilitating its membrane translocation and phosphorylation of VE-cadherin at adherens
junctions (AJ). Additionally, mass spectroscopy revealed that Latexin physically interacts with several other
proteins, including clathrin and AP2, suggesting a role in endocytic trafficking, and syntaxin-3 and SNAP3,
suggesting a role in exocytosis. Consistent with this latter mechanism, we found that Latexin deficiency reduced
von Willenbrand factor secretion from lung endothelium. Taken together, these observations lead us to propose
the following central hypothesis regarding the role of Latexin in lung endothelial biology and the pathogenesis of
endothelial dysfunction in ARDS. We hypothesize that Latexin plays a pathogenic role in driving agonist-
induced endothelial dysfunction in the lung and that inhibiting its interactions with other key proteins will
reduce the severity of pulmonary edema, lung inflammation and microvascular thrombotic complications
in experimentally-induced ARDS. To test this hypothesis, we propose 3 independent but mechanistically
linked Specific Aims. In Aim 1, we will establish that endothelial-specific deletion of Latexin enhances
endothelial barrier protection and reduces microvascular thrombosis and mortality to LPS in mice. In Aim 2, we
will delineate the molecular mechanisms by which Latexin regulates VE-cadherin membrane bioavailability at
endothelial AJs by performing various in vitro and in vivo loss- and gain-of-function studies for genes linked
to Src-mediated VE-cadherin phosphorylation and clathrin-mediated endocytosis in ECs. In Aim 3, we will
delineate the molecular mechanisms by which Latexin mediates vWF secretion from endothelial cells, focusing
on its role in SNARE complex formation. In toto, this proposal will establish the mechanisms by which Latexin
regulates key pathological behaviors in lung endothelium and provide direction for developing novel therapeutic
approaches for inflammatory vascular diseases of the lung, such as the ARDS.

Public health relevance
NARRATIVE: This grant will test the hypothesis that Latexin contributes to endothelial dysfunction and microvascular thrombotic complications in the lung and that pharmacological strategies inhibiting its activities ameliorate the severity of acute lung injury in mice. Studies in this application are designed to advance our understanding of lung endothelial biology and foster the development of new approaches to the treatment of inflammatory vascular diseases of the lung, such as the acute respiratory distress syndrome.